Cancer Immunology Research Program

CANCER IMMUNOLOGY RESEARCH PROGRAM
PROGRAM CODE: CI

PROJECT SUMMARY/ABSTRACT
The overarching mission of the Cancer Immunology (CI) Research Program is to improve understanding of the
host response to cancer and to discover and test novel approaches to harness that response to improve
patient outcomes. The program was ranked outstanding in the last renewal. Drs. Dhodapkar and Chen lead
the CI program and are experienced investigators with a >15-­year history of sustained NCI funding and
multiple contributions in cancer immunology. Dr. Chen pioneered the targeting of the PD-­1/PD-­L1 pathway in
cancer, which has transformed cancer immunotherapy. CI consists of 33 members from 8 different
departments whose work revolves around four major aims: 1) understand the mechanisms underlying the
capacity of the immune system to inhibit tumor growth, as well as mechanisms that drive tumor immune
resistance;? 2) discover and test new approaches for promoting anti-­tumor immunity;? 3) study the mechanistic
links between inflammation and cancer;? and 4) undertake targeted therapeutic trials that utilize novel endpoint
assessment and build on the fundamental discoveries of Aims 1-­3. CI experienced a 15% increase in total
funding ($12M direct), as well as a 21% increase in NCI funding ($2.3M direct). Collaborations remain
strong with 17% intra-­ and 30% inter-­programmatic publications.
Translational efforts in the CI program are abundant, in particular with our tumor immuno-­oncology (TIL) lab.
Major collaborations exist with the Lung Cancer SPORE and SU2C efforts (DT), the GU/Bladder group (ST),
the Phase I team (DT), Head and Neck Cancers (DT), and the colorectal cancer SU2C collaborative (CPC).
Samples are being analyzed in numerous CI clinical trials to investigate the mechanisms underlying resistance
and response to immune therapies. Human tissue has been collected under multiple protocols and used for
patient-­derived xenograft (PDX) and humanized models.
During the last funding period, immune checkpoint blockade for cancer treatment has emerged as one of the
most exciting and promising new approaches to treat cancer in decades. CI has played a leading role in
bringing this revolutionary approach into the clinic with several seminal studies that introduced checkpoint
blockade targeting the PD1/PD-­L1 pathway in the therapy of melanoma, lung, gastric, head/neck, and bladder
cancer. YCC has been at the forefront of the immuno-­oncology revolution, playing lead roles in the earliest
studies and, eventually, FDA approvals of immune checkpoint blockade and combination blockade, the
identification of new checkpoint inhibitor targets, the development of unique animal models, and important
advances in basic immunobiology, especially in T-­cell biology. Over the last five years, the growth of our
clinical trial efforts in this area has enabled reverse translation using clinical specimens, which bolsters SPORE
and other multi-­PI grants. CI will continue as a highly interactive program dedicated to improving understanding
of the host response to cancer and developing novel approaches to improve outcomes.